Structure And Stabilization Of The Bacterial Nucleoid

The genomic DNA of Escherichia coli occurs in compact bodies known as nucleoids. Organization and structure of nucleoids are poorly understood. Compact, characteristically-shaped, nucleoids isolated by the polylysine-spermidine procedure were visualized by DNA fluorescence microscopy. Treatment with urea or trypsin converted compact nucleoids to partially expanded forms. The abrupt transition that occurred in urea solutions was accompanied by release of most DNA-associated proteins; the transition point between compact and partially expanded forms was not changed by the loss of the proteins nor was it changed in nucleoids isolated from cells after exposure to chloramphenicol or from cells in which Dps, Fis, or H-NS and StpA had been deleted. Partially expanded forms that had been stripped of most DNA-associated proteins were efficiently recompacted by polyethylene glycol 8000, a macromolecular crowding agent, in an abrupt transition. DNA-associated proteins are accordingly suggested to have relatively little effect on the phase-like behavior of the cellular nucleoid. Partially expanded forms became dispersed upon RNase exposure, indicating a role of RNA in maintaining the partial expansion. Changes in the urea transition indicate that a previously described procedure for nucleoid compaction may have an artifactual basis, and raise questions about reports of repetitive local structures involving the DNA of lysed cells. This material has been prepared and submitted for publication.